Novel Statistical Methods for Confounded and Incomplete Network Data

Project Summary
Studies of public health interventions aimed at controlling the spread of infectious diseases such as HIV/AIDS
or COVID19 often face important methodological challenges due to pervasive network dependence,
confounding and widespread missing data. Each of these complications has separately received considerable
attention, however, methods to tackle them when they coexist are currently lacking. We will develop new
statistical methodology, specifically causal identification theory and robust estimation theory which we plan to
apply to address pressing scientific questions in infectious disease research using data from two randomized
trials and two observational studies with data at hand, where both missing data, and network structure occur
including the HAALSA South African Study, the Networks, Norms, and HIV/STI Risk Among Youth
(NNAHRAY) study, and the Botswana Combination Prevention Study (BCPP) and the Home-based
Interventionto Test and Start (HITS) cluster randomized trial. Success in the proposed research will not only
allow for robust conclusions to be drawn from data in the above studies, despite the presence of missing data,
the potential for confounding bias, and complex social network structure; it will also provide a methodological
template for addressing similar questions beyond these four studies as confounded, missing and dependent
data are routinely co-occurring complications in Social and Infectious Disease Epidemiology.

Public health relevance
Project Narrative Complex studies of social interactions and infectious diseases, such as HIV/AIDS and COVID-19, generally feature complex types of missing data and individuals forming social networks. While methods for handling confounding, missing data, and network-induced dependence between experimental units are both well- developed, these analytic complications have not been studied together. We propose to develop a suite of new methodologies to address complications arising in studies where confounded, missing and dependent data occur together and to use them to address questions in HIV research involving interconnected units.